Investigating tandem repeat variation as a cause of Alzheimer's disease from exome sequencing data

Tandem Repeat Expansions (TREs), most commonly of triplet repeats such as poly(CAG), are known to
underlie >30 different human neurological diseases. While the majority of TREs identified to date have been
found in late-onset neuro-degenerative disorders such as hereditary ataxias and Huntington disease, TREs
have been identified in patients with AD and certain types of dementia. In addition to expansions of short
tandem repeats (those with motif sizes between 1 and 6 base pairs), copy number variation of larger repeats
with motifs ≥20bp, also known as Variable Number of Tandem Repeats (VNTRs), has recently been linked to
risk of AD. However, despite this evidence that variation in tandem repeat (TR) sequences can act as the
causative mutations in some cases of AD and dementia, there have been no concerted efforts in AD cohorts to
either systematically screen for novel TREs, or to genotype VNTR copy numbers.
Newly developed bioinformatic approaches that can be applied to analyze Whole Exome Sequencing
(WES) data now provide an opportunity to fill this knowledge gap. Utilizing the expertise and knowledge that
we have gained working on other large datasets, we propose to apply these approaches to analyze >20,0000
exomes generated by the Alzheimer's Disease Sequencing Project that are available to the community, and
will use these data to investigate two hypotheses:
1. We hypothesize that some cases of AD are caused by rare, highly penetrant pathogenic TREs. Using
novel bioinformatic tools that can identify TREs, we will search for rare TREs that are observed only in AD
samples, or which show significant enrichment in AD cases compared to controls, and thus are likely
causative for AD. Potentially pathogenic TREs will then be validated by PCR or long-read sequencing in
available DNA samples.
2. We hypothesize that common polymorphic copy number variation of VNTRs can act as genetic risk
factors for AD. We have developed a novel approach based on read depth to estimate copy number of
VNTRs from exome sequencing data. We will analyze available WES data from 9,226 sporadic AD
samples and 10,151 unrelated controls, generating copy number estimates for ~4,100 genic VNTRs that
are represented in WES, which will be used to perform association analysis of VNTR copy number with
AD status in a case:control study.
Given that TREs, and polymorphic variation in VNTRs, both represent established mutational mechanisms that
contribute to a variety of late-onset neuro-degenerative conditions, we believe that the study of TR variation in
AD represents a logical step that has a high likelihood of uncovering novel genetic causes of AD.

Public health relevance
Although >30 tandem repeat expansions (TREs) have been identified in a variety of late-onset neurological diseases, including in patients diagnosed with Alzheimer’s disease (AD) and dementia, there have been no concerted efforts to systematically screen for novel TREs in AD cohorts. Similarly, recent studies have identified copy number variations in large tandem repeats as a risk factor for Alzheimer’s disease. Using novel bioinformatics approaches, in this proposal we will analyze exome sequencing data from >10,000 AD samples and >10,000 controls generated by the Alzheimer's Disease Sequencing Project to identify novel TREs and large tandem repeat variants that are responsible for AD.